Indiana Alzheimer Disease Center

DESCRIPTION (provided by applicant): The Indiana Alzheimer Disease Center (IADC) is established on the campus of Indiana University School of Medicine. It is comprised of six cores: Administrative Core, Clinical Core, Data Management and Statistics Core, Neuropathology Core, Education and Information Transfer Core and Neuroimaging Core. The mission of the IADC is: 1) to support and carry out research on Alzheimer disease (AD) and other neurodegenerative dementias, 2) to serve as shared research resources that will facilitate research in AD and other dementias, 3)distinguish them from the processes of normal brain aging and mild cognitive impairment (MCI), 4) provide a platform for training, 5) develop novel techniques and methodologies, and 6) translate these research findings into better diagnostic, prevention and treatment strategies. The focus of the IADC is on behavioral neurology, clinicopathological correlations, biochemistry, and genetics of AD, frontotemporal dementia and Parkinsonism linked to chromosome 17 (FTDP-17), Gerstmann-Strussler-Scheinker disease (GSS), Parkinson disease and other hereditary diseases associated with abnormal protein accumulation.

Public health relevance
PUBLIC HEALTH RELEVANCE: It is estimated that as many as 5 million Americans have AD. The Indiana Alzheimer Disease Center provides an environment and resources directed towards fostering and coordinating research and educational activities on AD and other dementing illnesses.